Proposed correlation between birth size &salt sensitivity of adult BP

We will test: 1. There is an inverse correlation between birthweight and adult blood pressure. 2. Individual in the lowest tertile of birthweight will show salt-sensitivity as shown by their blood pressure and plasma hormone levels compared to other tertiles of birth weight. 3. The proposed mechanism of action is that individuals with a low birthweight have been "programmed" in utero to inappropriately maintain or elevate renin and/or aldosterone plasma levels in respone to a sodium challenge, whereas normal individuals will suppress renin and/or aldosterone t increase natriuresis and polyuria.